Open Drug Discovery Center for Alzheimer's Disease

PROJECT SUMMARY BIOINFORMATICS CORE
The Open-AD Bioinformatics Core (Bioinf Core) will create scorecards to prioritize community contributed
Alzheimer’s disease therapeutic hypotheses and protein targets by performing data-driven unbiased
assessments of genetics, multi-omics, neuropathology, prior biological, and mechanistic evidence. After
hypothesis and target prioritization, the Bioinf Core will openly distribute hypothesis and target scorecards to
the research community, along with the prioritization and analysis tools and data. The overarching goals of the
Bioinf Core are to establish a comparable assessment across hypotheses and targets that the Open-AD
Steering Committee can use to make decisions as to whether to develop TEPs for a particular hypothesis or
target; provide the community with these benchmarks for any given hypothesis that is nominated; annotate
hypotheses with mechanisms that can be tested by the Assay and Screen Core; and integrate diverse and
complimentary evidence in new ways to perform prioritization that will be shared with the community as new
bioinformatic tools. To achieve these goals, we have assembled a team of computational researchers with
complementary expertise in genetics, multi-omics, and neuropathology. The Core will be led by a team at Sage
Bionetworks, a non-profit biomedical research organization, that has a history of leading innovative and
collaborative research projects and has specialties in Alzheimer’s disease and multi-omic analyses.

Public health relevance
The narrative is attached in overall section.